Health Effects of E-cigarette Use on Brain Functions and Cognitive Development among Adolescents: A US Population-Based Study

Project Summary
Electronic Nicotine Delivery System (ENDS) use has been a major public health concern. The U.S. Food and
Drug Administration (FDA) continues to cite health effects as a chief rationale in FDA enforcement priorities and
marketing denials. Childhood to adolescence represents a critical period with rapid development in brain
maturation. Combustible cigarette smoking during adolescence can negatively impact brain development, and
animal models also show that nicotine exposure in adolescent rodents slows brain maturation, including the
prefrontal cortex. However, the impact of rising ENDS use on youth brain functions and cognitive outcomes is
poorly understood. Vaping delivers much lower levels of tobacco smoke chemicals but similar levels of nicotine
compared to cigarette smoking. Studying the effects of vaping on brain maturation can illuminate nicotine effects
without tobacco smoking. Importantly, there is a dearth of evidence on the relative effects of exclusive ENDS
use vs. combustible cigarette smoking on youth brain maturation, which is critical to the FDA’s regulatory actions
on ENDS and prioritizing public health programs. This population study will analyze the longitudinal Adolescent
Brain Cognitive Development (ABCD) study with 11,878 youth aged 9-10 years old at baseline from 21 U.S.
study sites, to assess the effects of exclusive ENDS use on youth’s brain structure and cognitive performances
and further examine potentially differential effects of vaping vs. smoking on neurocognition. The study will link
the first 5 biannual waves of ABCD magnetic resonance imaging (MRI) data during 2016-2024 with semiannual
tobacco use assessments and annual behavioral measures by Subject ID to create a harmonized longitudinal
dataset. In Aim 1, the team will prospectively examine the effects of exclusive ENDS use (vs. never tobacco use)
on whole-brain morphometric measures (e.g., white/gray matter, cortical thickness). In Aim 2, the team will
assess the longitudinal associations of exclusive ENDS use (vs. never tobacco use) on attention, memory,
executive function, emotion regulation, and reward processing at the cognitive level, using validated behavioral
tasks sensitive to youth development (e.g., NIH Toolbox), and at the brain level using functional MRI tasks. In
both Aims 1 and 2, we will further test whether differences in brain maturation are negatively associated with
vaping frequency, intensity, and duration among ENDS users. In Aim 3, the relative effect of exclusive ENDS
use vs. cigarette smoking on whole brain structure and NIH Cognition Toolbox will be tested. This study is
innovative by 1) leveraging the largest brain development and child health study with state-of-the-art
neurocognitive assessments, and 2) applying the mariginal structural modeling to handle time-dependent
exposure and time-varying confounders, thus allowing for unbiased effect estimation and teasing out potentially
reverse causality. This study is also significant in providing vital evidence on vital evidence of vaping effects on
brain health, thus providing vital evidence to inform effective regulatory actions and public policies.
1

Public health relevance
Project Narrative This population study is centered on advancing our knowledge of exclusive ENDS use (vs. no tobacco use) in youth brain structure (Aim 1) and cognitive performance (Aim 2) as well as relative effects of exclusive ENDS use and cigarette smoking on brain health (Aim 3). Identifying the health effects of ENDS use on brain maturation is critical to informing effective regulatory actions and policies including making decisions about the potential risks of ENDS to public health.